Nonresponse of Patient-reported Outcomes in Routine Cancer Care

PROJECT SUMMARY/ABSTRACT
Patient-reported outcome (PRO) measures, or PROMs, are powerful tools in cancer care to enhance clinician-
patient communication, identify problematic symptoms and treatment priorities, facilitate shared decision-making,
and prolong survival. Nonresponse significantly undermines the representativeness of PRO data that is routinely
collected as part of clinical care, thereby compromising its utility for promoting high-value, equitable patient-
centered care in cancer clinics. The lack of adequate representativeness also hampers the use of routinely
collected PRO data for quality improvement and value-based healthcare. There is an urgent need to delineate
the representativeness of PRO data collected in routine cancer care, identify the underlying causes of
nonresponse, and develop novel methods to ensure data representativeness. Despite compelling evidence that
expanding the reach of PROMs collection to underrepresented patients and improving their PROMs completions
are critical to ensure the representativeness of routinely collected PRO data, most of the current research
focuses on methods to increase collection instead of methods to enhance PRO data representativeness. The
overarching goal of this proposal is to characterize and delineate the causes of nonresponse and devise
mitigation strategies to improve the representativeness of PRO data collected in routine cancer care. By
examining the data of the Patient-Reported Outcomes Measurement Information System Global-10 measure
collected as part of routine care at seven Radiation Oncology clinics within the Mass General Brigham healthcare
system, we will (Aim 1) characterize the nonresponse of the Global-10 across clinic, provider, and patient levels;
(Aim 2) identify multilevel causes of nonresponse and potential strategies to improve representativeness in
PROMs collection; and (Aim 3) develop effective modifications to missing-data methods to enhance the
representativeness of pre-existing PRO data. Our expected outcomes are generalizable knowledge and
strategies to address nonresponse in PROMs, enhancing PRO data representativeness in routine cancer care.
The successful completion of this project will elucidate the characteristics of PROMs nonresponse and its
intricate associations with multilevel factors of successful large-scale PROMs collection in diverse patient
populations. Insights from this endeavor will also guide the evolution and development of PROMs collection
programs to expand their reach to underrepresented cancer patients and improve data representativeness. This
will, in turn, enable the utility of PRO data for quality improvement and high-value, equitable patient-centered
cancer care.

Public health relevance
PROJECT NARRATIVE Nonresponse significantly undermines the representativeness of patient-reported outcome (PRO) data that is routinely collected as part of clinical care, thereby compromising its utility for facilitating high-value, equitable patient-centered care in cancer clinics. Using a multilevel framework and a mixed-methods approach, the proposed project strives to augment the understanding and management of nonresponse in PRO data collected as part of routine cancer care. This initiative will set the stage for harnessing pre-existing, routinely collected PRO data for equitable healthcare and quality improvement while also planning for future interventions aimed at expanding the reach of PRO data collection to underrepresented populations.